Self-driving laboratories for autonomous exploration of protein sequence space

PROJECT SUMMARY/ABSTRACT
We propose to develop fully autonomous “self-driving laboratories” to rapidly engineer enzymes for broad
applications in biomedicine and biocatalysis. Our approach mimics the methodology of a protein engineering
researcher with an AI layer that builds an understanding of protein sequence-structure-function and plans
experiments to test specific protein design hypotheses, and a robotic system that experimentally tests
designed proteins by synthesizing genes, expressing proteins, and performing biochemical measurements of
enzyme activity. Seamless integration between the intelligent agent and experimental automation enables fully
autonomous design-test-learn cycles to understand and optimize the sequence-function landscape. Self-
driving laboratories will revolutionize the fields of biomolecular engineering and synthetic biology by automating
highly inefficient, time consuming, and laborious protein engineering campaigns, enabling rapid turnaround,
and allowing researchers to focus efforts on important downstream applications.

Public health relevance
PROJECT NARRATIVE This proposal aims to develop fully autonomous self-driving laboratories that quickly and efficiently engineer proteins without human intervention, feedback, or bias. Engineered proteins have broad biomedical applications including as antibody and enzyme therapeutics, biocatalysts to synthesize pharmaceutical compounds, molecular imaging agents, and sensitive molecular diagnostics.